Structural study of direct associations between cellular RNA polymerase and regulatory factors during the transcription cycle

Project Summary
The long-term goal of our research is to understand transcription mechanisms of cellular RNA polymerase.
Our research has made major contributions to provide structures of RNA polymerase at the different stage
of transcription cycle. During the next five years, we will continue to study the transcription machinery in
bacteria and archaea to provide insights of the fundamental mechanism of transcription, which is conserved
from bacteria to human.
Over the last 20 years, X-ray crystallography has been playing a major role in the structural biology of RNA
polymerase and revealed many important structures. RNA polymerases at evident stages in the mainstream
of the transcription cycle are often referred to RNA polymerase core enzyme, holoenzymes, open complex
with a strong promoter, transcription initiation and elongation complexes. These structures have been well
characterized due to their stable natures. A challenge in the structural biology of cellular RNA polymerase is
to visualize transient interactions of RNA polymerase with other regulatory factors and ligands that occur in
between each evident stage in the mainstream or at the branched pathways from the mainstream of
transcription cycle. Due to their elusive natures, crystallization of such macromolecular assemblies has
been a bottleneck and thus limited the approach by X-ray crystallography.
In the last couple of years, the resolution of macromolecular structures determined by cryo-electron
microscopy (cryo-EM) has been drastically improved due to multiple technical advances, allowing us to
visualize heterogenous and large assembly of macromolecular complexes. We will use structural biology
methods including both cryo-EM and X-ray crystallography together with other biochemical approaches to
visualize these transient interactions and investigate their effects for transcription process. Major targets of
our study are: 1) the interaction between the Escherichia coli RNA polymerase and DksA/ppGpp for
transcription regulation during the stringent response; 2) the interaction between bacterial RNA polymerase
and ATP-dependent motor enzyme for rescuing stalled RNA polymerase at the end of transcription cycle;
and 3) the interaction between archaeal RNA polymerase and ATP-dependent transcription termination
factor Eta for disrupting a stalled transcription elongation complex to initiate the transcription-coupled DNA
repair.

Public health relevance
Project Narrative Gene expression by cellular polymerase is fundamental to all life forms and investigating the transcription process is critical for understanding cell development, maintenance, and disease. The proposed studies regarding the structure and function of cellular RNA polymerase may lead to new avenues for drug discovery and preventing disease.